Cellular and molecular mechanisms in Age Related Macular Degeneration & Uveitis

Subtypes of Macrophages and Interaction of Macrophages with the RPE. In collaboration with Dr. Siamon Gordon in Oxford and Dr. Miller at the NEI, we have initiated studies on human macrophages focusing on 1) the interaction of human macrophages with human retinal pigmented epithelial cells and 2) phenotypic and functional heterogeneity of human macrophages and its implication in autoimmune intraocular inflammatory diseases. We have found that human RPE cells can interfere with the normal processes of differentiation and maturation of macrophages. We then evaluated monocytes' role in the development of intermediate, posterior and panuveitis. Preliminary data showed that immuno-suppression enrich anti-proinfllammatory monocytes in patients' peripheral blood, implying that regulatory monocytes can serve as a prognosis marker for uveitis. We further showed that different types of monocytes interact T cells in different modes. Immune factors leading to CNV By adapting and modifying a commonly used laser induced CNV mouse model, we have established a strategy to investigate the involvement and potential mechanisms of immune responses in CNV, the most common complication in AMD and other important eye diseases. We have combined flow cytometry, vibrotome immunohistochemistry and flat-mount techniques plus confocal immunomicroscopy to evaluate the model. We have discovered that there is a dynamic and complex movement of immune cells during the development ofCNV in the mouse. Macrophages have been implicated in the pathogenesis of AMD. Class A scavenger receptors, SR-A and MARCO, are expressed on macrophages and are associated with macrophage function. The goal of this study is to examine the role of macrophage scavenger receptors in immune cell recruitment and the formation of CNV. Laser photocoagulation was performed in Wild Type and knockout mice with deletion of SR-A (SR-A-/-), MARCO (MARCO-/-), or both SR-A and MARCO (DKO). Immune cell recruitment at different time points and CNV lesions at 14 days after laser treatment were evaluated through immunostaining and confocal microscopy. Microarray analysis was performed in eyes 1 day after laser injury. Wild Type eyes showed higher chemokine/receptor expression compared with knockout eyes after laser injury. Scavenger receptor deficiency markedly impaired the recruitment of neutrophils and macrophages to CNV lesions at 1 day and 3 days post laser injury, respectively. Significantly reduced CNV volumes were found in the eyes from scavenger receptor knockout mice compared with Wild Type mice. The deficiency of scavenger receptors impairs the formation of CNV and immune cell recruitment. Our findings suggest a potential role for scavenger receptors in contributing to CNV formation and inflammation in AMD. Complement and the immune response. Several reports have associated SNPs of complement factor H with either susceptibility to or protection against AMD. This association has been attributed to involvement of the innate immune system, presumably through macrophage activity and Toll-like receptors. We have looked at this question differently; rather that complement and its components may be part of the acquired immune system. We have showed that C5a promoted IL-22 and IL-17 expression from human CD4+ T cells of AMD patients and normals accompanied by the expression of the transcription factor BATF. This effect was dependent on B7, IL-1beta and IL-6 expression from monocytes. Intriguingly, we found significantly increased levels of IL-22 in the serum of 22 AMD patients and the vitreous of one AMD patient as compared to non-AMD controls, strongly suggesting possible roles of IL-22 and IL-17 in the inflammation that contributes to AMD. We also showed that IL-22 directly decreased retinal pigment epithelium (RPE) viability. RPE loss is a consistent feature of the development of advanced AMD. In addition to the role of C5a in T cell differentiation, C5a also decreases human RPE cell viability and abrogates the suppressive effect of RPE on T cells. Thus, our data suggest an underlying mechanism of chronic inflammation leading to retinal degeneration which may herald a new approach to treat AMD.Plans are being made based on these observations to begin a randomized study to prevent the expression of late AMD.